Oklahoma Tribal, Rural, Urban Cancer Screening Trial ACCESS Hub

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the NOSI identified as NOT-CA-24-111. All activities
supported by this administrative supplement will occur in the Stephenson Cancer Center (SCC) Oklahoma
Tribal, Rural, Urban Cancer Screening Trial (OK TRUST) ACCESS Hub, a member site of the National Cancer
Institute (NCI) Cancer Screening Research Network (CSRN). The overarching goal for the OK TRUST
ACCESS Hub is to enhance capacity for increasing cancer screening trials accrual and participation among
tribal, rural and urban populations across Oklahoma. OK TRUST is designed to enroll large numbers of
participants from tribal, rural, and low-income urban populations, which have disproportionately high cancer
rates but low participation in clinical trials at the national level. Given the historical distrust between American
Indian communities and academic researchers, it is notable that several Tribes and American Indian-serving
clinical facilities are participating in this project, which collects biospecimen data. Funds from this
Administrative Supplement request will address critical aspects of the Vanguard Study identified since our
original application. Specifically, we seek funding for two additional Cancer Screening Research Coordinators
(CSRCs) to manage the complex requirements of recruitment, enrollment, consent, data collection, participant
retention, and navigation of diagnostic testing. One CSRC will be fluent in Spanish to support affiliates with
large Spanish-speaking populations, and another will have expertise in tribal data protection. Additionally, we
request funding for participant gift cards to improve retention, including for a two-year follow-up interval, which
was not included in our original budget. We also seek funds to cover the costs of venipuncture biospecimen
collection at Affiliate Organization facilities, some of which will rely on study funds for this purpose. Since our
original application, we have learned that a higher proportion of results from the two multi-cancer early
detection (MCED) tests selected for the Vanguard Study will be positive than originally estimated. As a result,
we are requesting additional funding for diagnostic testing, beyond the in-kind contribution from the SCC
included in the original proposal. This supplemental funding will enable OK TRUST to complete its proposed
aims for the Vanguard Study, including enrolling a diverse participant pool and providing follow-up for those
with positive results. It will also address the additional complexity and costs identified since the original
application, allowing the OK TRUST ACCESS Hub to successfully recruit participants from high-cancer-rate
communities that have often been excluded from cancer research.

Public health relevance
PROJECT NARRATIVE Cancer affects all populations, but some communities shoulder a heavier risk than others. In particular, persons from tribal, rural and urban inner-city communities face daunting challenges in accessing cancer screening and diagnostic follow-up services. The SCC Oklahoma TRUST ACCESS Hub will bring recent advances in cancer screening to high-risk tribal, rural and urban inner-city populations by increasing access to the Vanguard Study and future cutting-edge cancer screening trials.